Clinical and Community Based Research Resource Core 1

PROJECT SUMMARY/ABSTRACT (CCBR-RC1)
The Clinical and Community Based Research Resource Core (CCBR-RC1) will continue as the primary UTMB
OAIC resource for clinical research while expanding to support community-based research aimed at
eliminating barriers to research participation for populations experiencing health disparities. In the new cycle,
the CCBR-RC1 will support research on mechanisms underlying function loss and recovery, trajectories of
physical function and disability in older adults, and the development and testing of novel treatments and
technologies. Additionally, the Core will support bilingual community-based studies on chronic disease
management and prospective, population-based studies on older adults with chronic disabling conditions. All
CCBR-RC1 activities will align with the broader OAIC theme: Enhance functioning in older adults with chronic
disabling conditions by reducing health disparities.
The Specific Aims of the CCBR-RC1 are:
Aim 1. Support clinical and community-based research relevant to the OAIC theme.
Aim 2. Train and support OAIC Scholars and investigators on novel approaches to increase
participation of underserved older adults in clinical research.
Aim 3. Strengthen partnerships with internal and external collaborators to facilitate Specific Aims 1
and 2 and promote dissemination to communities of interest.
Our goal is to drive change in aging research by promoting excellence through evidence-based approaches
across the study lifecycle, ensuring comprehensive study support, use of standardized regulatory procedures,
and building trust and enduring relationships with the broader community. This Core will develop new
resources for Scholars and other investigators designed to minimize recruitment and retention failures and
prevent timeline overruns. The CCBR-RC1 will ensure adherence to best practices for including underserved
populations and standardize the collection of relevant health determinants and functional status measures
across all OAIC studies involving human subjects. We will also develop and expand partnerships with new
outpatient clinical settings and implement innovative methods for documenting health disparity metrics. Along
with our partners from the Texas Southern University College of Pharmacy and Health Sciences, we will
participate in a national consortium to develop and test new approaches for optimizing the recruitment of
underserved populations.